ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Administrative Core will serve to coordinate all reports to the NIH and other designated officials, arrange the annual EAC meeting, administer finanicial aspects of this grant and assist junior investigators in manuscript and grant preparation.